Data Management Core

CSCMI DATA MANAGEMENT CORE SUMMARY
The Data Management and Biostatistics Core (“Data Core”) provides data management, statistical, and
bioinformatics support for the Center for the Study of Complex Malaria in India (CSCMi). The Core collects
and manages data from all our participating study sites, ensuring uniformity of procedures and high data quality.
Data from our field- and hospital-based epidemiology projects and vector survey projects are stored in a bespoke
REDCap database and in Google Cloud instruments designed and managed by the Data Core. Data capture,
entry, and upload to the REDCap database are implemented on electronic tablet hardware supported by the
Data Core, via digital forms designed by the Data Core, guided by researcher needs. Expertise and support for
statistical and bioinformatics analysis, manuscript development and proof reading, and data
mapping/visualization are also part of Data Core services. Lastly, the Data Core is responsible for the rapid
release, to ClinEpiDB, GenBank, VEuPathDB, and the broader scientific community, of datasets (‘omic,
epidemiologic, code), analysis tools, and other resources generated in adherence to the requirements and
timelines described in the Data Management and Sharing Plan, but also in accordance with Government of India
guidelines.